Oral to Gut Microbiome Transmission in Periodontitis and Type 2 Diabetes

Project Summary
Periodontitis and Type II Diabetes (T2D) are co-occurring diseases and among the most prevalent
chronic illnesses in the United States with an estimated 46.5% of adults suffering from the former, 9.4% adults
suffering from the latter, and 62.3% of diabetic adults older than 65 burdened by both. T2D, characterized by a
state of chronic systemic inflammation, can lead to periodontitis via dysregulated host immune responses and a
positive feedback loop between systemic inflammation and oral dysbiosis. The observation that periodontitis
adversely affects glycemic control, insulin resistance, and diabetic complications like neuropathy, cardiovascular
disease, and even death is well accepted, but the underlying mechanism is unknown. Periodontitis has emerged
as a potential modifier of the gut microbiome, whose role in regulating systemic and metabolic health is
increasingly being recognized. Multiple studies point to gut microbiome dysbiosis as a contributor to metabolic
disorders, inflammatory bowel disease (IBD), colorectal cancer and rheumatoid arthritis. Combined with
evidence oral dysbiosis is associated with gut microbiome compositional changes, and, that oral microbes make
up gut microbiome signatures in T2D, rationale exists for the oral-gut microbiome axis as a link between
periodontitis and diabetes. The goal of this NRSA F30 proposal is to evaluate the effect of periodontitis, and its
associated mouth microbiome dysbiosis, on metabolic pathways of the gut microbiome important to metabolic
disorders and T2D. The overarching hypothesis of this proposal is that periodontitis alters the gut microbiome
vis oral-to-gut strain transmission to contribute to metabolic dysfunction and inflammation in T2D. The purpose
of Aim 1 is to determine if microbial specific strain-level genetic variation and oral dysbiosis are associated with
functional changes in the gut microbiome. The purpose of Aim 2 is to test oral-to-gut strain transmission as a
mechanism by which periodontitis alters the gut microbiome, and contributes to poor outcomes related to T2D.
Using subject-matched plaque and feces samples, the oral and gut microbiomes will be characterized at strain-
level resolution, and metabolic profiles will be reconstructed for each microbiome. The experiments outlined in
this proposal will determine the role of specific oral strains and oral-to-gut strain transmission in contributing to
the pathologic systemic effects of periodontitis seen in T2D. This work will take place at the University at Buffalo,
School of Dental Medicine, in the laboratory of Dr. Patricia Diaz, who is an expert in microbiome research. The
training plan is tailored for development as a physician-scientist in the field of infectious disease, and will include
clinical preceptorships in infectious disease and endocrinology in order to gain cross-disciplinary experience,
reflecting the research goals of this proposal. These longitudinal clinical preceptorships will be with successful
physician-scientists, who also will be directly involved in the proposed research, thereby providing integrated
mentorship over the course of the fellowship.

Public health relevance
Project Narrative The relationship between periodontitis and type II diabetes (T2D), co-occurring diseases that are among the most prevalent chronic illnesses in the US, is characterized by the former’s ability to increase the risk of severe diabetic complications, including death, in patients with both diseases. This project aims to understand the effect of periodontitis, and its associated mouth microbiome dysbiosis, on metabolic dysfunction in T2D. This project has an immediate impact on the understanding of periodontitis pathophysiology in systemic metabolic dysfunction.